Administrative Core

Core A Abstract
Core A will provide administrative support and oversight of the program project. An administrative assistant will
provide support for financial management and administration of the program. The administrative core will also
organize bi-monthly meetings to facilitate scientific exchange between program participants and provide a
format for the evaluation of the scientific progress in individual projects. The core will also organize visits from
members of both intramural and extramural advisors and contribute to a small seminar program. Funds are
requested under Core A to support subscription fees for structural biology software support from the SBGrid
and to maintain yearly software licenses for computer programs used for graphing, biochemical data analysis
and for preparing high quality graphics.

Public health relevance
Core A Narrative Core A provides administrative support and scientific leadership for the program.